TX RRT

TEXAS RAPID RESPONSE TEAM PROJECT SUMMARY/ABSTRACT - RFA-FD-
23-019
The Texas Rapid Response Team (TRRT) seeks to protect the public health of
Texans by reducing instances of foodborne illness and food contamination. This is to
be achieved through regular communication, outreach, information sharing, and
training.
TRRT proposed specific aims are paraphrased below:
• Continue regularly scheduled TRRT steering committee and workgroup
meetings.
• Participate in required and relevant conferences and meetings.
• Maintain our working relationship with TRRT partner agencies.
• Participate in opportunities to present TRRT information potential TRRT
partners.
• Promote environmental assessments during foodborne illness
investigations.
• Provide or seek relevant training opportunities.

Public health relevance
TEXAS RAPID RESPONSE TEAM PROJECT NARRATIVE - RFA-FD-23-019 The Texas Rapid Response Team (TRRT) seeks to protect the citizens of Texas by prioritizing the safety of food, which may be compromised by various circumstances. The TRRT partners possess multi-disciplinary expertise and inter- jurisdictional authority to respond to complex foodborne illness investigations and emergency situations. The TRRT uses collaboration, information exchange, resource sharing, and relevant training to limit the adverse effects of contaminated and unsafe foods.